Mood, Brain, and Development Unit

Under NCT03388606, we have achieved the following despite the pandemic, as of August 2020: Enrollment in Characterization: 45 (30 MDD; 15 HV) Enrollment in Outpatient Treatment: 12 outpatients enrolled (or were continuing in treatment) Enrollment in inpatient Treatment: 0 patients enrolled (or continued in treatment as a result of pandemic-related closures) As an indicator of the amount of work during the pandemic, the clinicians in my group had most of their contact with patients be virtual between since the onset of the pandemic. Also, as part of our research we have collected eight waves of data related to COVID already and have now submitted a relevant paper on the effects of the pandemic on mental health out of our sample.